First Enantioselective Syntheses of Bactobolins A, B, and Analogue Antibiotics

Since the commercialization of penicillin in 1928, antibiotics have been hailed as “magic bullets”. In recent years, however, the number of bacterial strains resistant to clinically used antibiotics has sharply increased. The lack of viable first-line treatments of these bacterial infections has forced clinicians to consider secondline antibiotic options such as polymyxins and aminoglycosides, traditionally avoided because of significant toxicity. Thus, the development of antibiotics with new mechanisms of action for the control of pernicious bacterial infections is of vital importance. The synthesis of natural products and simplified derivatives has been a very successful strategy for the enrichment of the anti-infective armamentarium; a variety of clinically used antibacterial, antimalarial, and antifungal compounds have their origins in natural molecules. The specific aims of this proposal are: 1. Completion of the first enantioselective syntheses of Bactobolins A and B, two broad spectrum natural product antibiotics whose mechanism of action is the inhibition of protein translation via binding to an unprecedented site of the 50S ribosomal subunit and displacing tRNA bound at the P site. 2. Generation and evaluation of a plethora of functional analogues for future medicinal chemistry efforts. The rationale for this proposed research is that its success would allow for access to a diverse collection of antibacterial compounds with modes of action that are likely mechanistically distinct from FDAapproved antibiotics. The expected outcome of this research is the completion of several important steps towards the timely development of new, broad-spectrum, tolerable antibiotics. The successful execution of the research proposed herein is expected to have a significant positive impact by aiding the global effort to reduce human morbidity and mortality resulting from pernicious bacterial infections.

Public health relevance
Multi-drug resistant bacterial infections are increasingly encountered by physicians and their patients. The ultimate goal of this proposal is to develop new weapons against pernicious bacterial infections through the precise synthesis of bioactive natural products and designed derivatives. This fits well within the core NIH mission of reducing human morbidity and mortality through scientific innovation.